Novel regulators of Gli-driven medulloblastoma

0-$!!1.2*8/%3#!45!$6!!&8'%!9%%#6#1!5!*6$*!!#+#!4#$%$$!#$!$#'!'!!**&!&$$!!*!$!$$$(!$!#!56%#'7!0+$!&#$,!&!!&!$!&!#3!#!#$$**#$!#!%#$!!!%&+!*!#!!4&%#0$!1#)$23%&!**!'*!!$*#&%$*+,!%!& !#!$#&#%##!!C$$#*###%!$%!!!!!*!9!32#!&$$**'%#$!#!8##!!+43##!!!2**$!B2'%$!!!:#'$;!)<!&!!$!#!%(!*'!C!!*!*=>!@=@#A! E

Public health relevance
The identification of novel druggable targets in SHH driven cancers has remained a major challenge in the field. To tackle this obstacle we have identified a novel set of such targets, using a focused siRNA screen, a candidate approach, or a proteomics approach. The goal of this proposal is to characterize a subset of such regulators and to validate their roles in vivo, using mouse and human orthotopic mouse models of MB.